INTERNAL COMMUNICATION SERVICES FOR NHLBI IOD AND OM

From a programmatic perspective, the primary thematic areas of focus for internal communications are:
• workforce development programs and engagement
• tools, policies, and information technology
• diversity and inclusion
• enterprise-wide campaigns (e.g., Blood Drive, CFC, etc.)
• reporting on staff and their contributions, staff research, programmatic activities, and
scientific portfolios to build community